FitMi AD: a safe and motivating computer-guided exercise system for individuals with MCI or mild dementia due to Alzheimer's disease

Alzheimer’s disease (AD) affects over 5 million older adults in the US. AD is associated with accelerated
deterioration in physical function, resulting in a higher risks of falls, decline in mobility, reduced quality of
life, and loss of independence. Exercise interventions for individuals with AD or mild cognitive impairment
(MCI) have shown promising improvements to overall health, physical function, and independence.
Unfortunately, routine exercise is difficult to maintain for these individuals due to safety concerns and the
need for supervision and guidance. To address this need, we developed an exercise guidance app for our
touchscreen Flint Tablet that connects to a sensorized, low-profile stationary cycle (Cycli). We evaluated
the feasibility of this system in promoting home exercise in individuals with MCI or mild dementia in a
Phase I SBIR. The exercise guidance app and overall approach received positive feedback. However, the
Cycli hardware had a number of critical issues that prevent it from being a viable home exercise option
for this population (e.g. it created a potential tripping hazard and was not engaging for some users). To
address these limitations, we propose in Phase II to integrate the guided exercise app developed in Phase
I with our existing FitMi system, which is a wireless, sensorized at-home exercise device originally
developed for individuals with stroke. We refer to this new system here as FitMi AD. The existing FitMi
hardware includes a patented, multipurpose wireless input device (a “Puck”) and a wearable wireless
input device (a “Clip”) that measure both movement and compression force. Thus, we believe that with
appropriate, clinically informed design improvements, FitMi AD will facilitate home exercise in individuals
with MCI or mild dementia due to AD. Specifically, in addition to incorporating the scheduling, tracking,
and goal-setting features developed and validated in Phase I, FitMi AD will include a new library of
exercises from Exercise: A Guide from the National Institute on Aging (NIA). FitMi AD will also use real-
time data from a Bluetooth heart rate monitor to automatically adjust the exercise intensity to achieve a
beneficial level of exertion. Our specific aims for this Phase II project are to: Aim 1) Perform structured
interviews with clinical experts and individuals with MCI or mild dementia due to AD and their caregivers
to optimize the design of FitMi AD (n=25); Aim 2) Develop the FitMi AD exercise software with iterative
expert and user feedback; Aim 3) Determine the safety and effectiveness of home-based exercise training
with FitMi AD in a randomized controlled trial with individuals with MCI or mild dementia due to AD
(n=30). Our hypothesis is that participants who exercise at home with FitMi AD will show significantly
greater improvements in physical function than the control group. If successful, FitMi AD will be a safe,
effective, and commercially viable home exercise tool for individuals with MCI or mild dementia due to
AD, thus improving their quality of life and reducing the burden on caregivers.

Public health relevance
This research is relevant to public health because it will help support the development and commercialization of a novel home exercise system for individuals with mild cognitive impairment or mild dementia. FitMi AD will help improve overall health, physical function, and promote a more autonomous lifestyle, leading to improved quality of life and reduced burden on caregivers. This will provide a pathway to a better life for millions of U.S citizens suffering from cognitive decline due to Alzheimer’s disease.